Predoctoral Training in the Physiology of Human Health and Disease (PHHD)

PROJECT SUMMARY / ABSTRACT
The study of physiology is at the core of modern biomedical research, which more than ever relies on integrating
fundamental concepts of whole animal and organ physiology with sophisticated molecular and cellular
approaches to investigate important questions related to human health and disease. Understanding mechanisms
underlying the function of various systems in the body that contribute to both normal and pathological physiology
is the fundamental prerequisite for all applied research in biomedical sciences allowing scientists to make
important and translationally relevant discoveries.
The Integrated Physiology PhD Program (IPHY) on the
University of Colorado Anschutz Medical Campus (CU AMC) is a multidisciplinary PhD training program that
prepares students for careers in biomedical research. Students in Integrated Physiology have opportunities to
explore how molecules, cells, organ systems, and organisms regulate complex physiological functions through
the integration of molecular, cellular, and physiological mechanisms. Our goal for this T32 program is to provide
interdisciplinary training in areas focused on (1) Metabolism, Nutrition, and Obesity; (2) Cardiovascular,
Pulmonary, Renal, and GI Physiology; and (3) Reproductive Physiology in an inclusive environment to support
a diverse group of IPHY students. Our students and faculty are united by common interests in the understanding
of the physiology of human health and disease; this program is designed to train students to become the next
leaders contributing to innovative and groundbreaking scientific discoveries. We will accomplish our goal through
the following objectives: (1) Improve the national need for interdisciplinary systems biology biomedical research
focused on human health and disease; (2) Fill a campus-wide need to advance training in biomedical integrated
physiology and translational science at the University of Colorado Anschutz Medical Campus; (3) Provide
student-oriented well-balanced training and career development opportunities; (4) Develop a diverse and
inclusive training environment focused on career development. To accomplish these goals, we will establish a
program named the Physiology of Human Health and Disease (PHHD) Training Program that will build upon
the success of the current IPHY PhD program. The PHHD T32 Training Plan will emphasize five specific areas
that will allow trainees to develop professional skills, including project management, leadership, teamwork, and
communication, including: i). Knowledge skills; ii). Innovative Technical Research skills; iii). Communication
skills; iv). Professional skills; and v). Training in Diversity and Inclusion. The overall vision is to support
predoctoral students in an inclusive and diverse environment that facilitates opportunities for a future generation
of physiologists to obtain training in integrative and translationally relevant research focused on human health
and disease, to foster creative, independent thinking combined with strong communication skills, and to provide
career development, professionalism, and leadership opportunities.

Public health relevance
PROJECT NARRATIVE The goal of this training program is to facilitate interdisciplinary training and education to the next generation of research scientists, science educators, and biomedical research advocates in areas focused on the physiology of human health and disease. Predoctoral students will learn to responsibly conduct research in areas focused on 1) Metabolism, Nutrition, and Obesity; 2) Cardiovascular, Pulmonary, Renal, and Gastrointestinal Physiology; and 3) Reproductive Physiology in an inclusive and diverse environment. Students will be trained on how cells, organ systems, and organisms regulate complex physiological and pathophysiological functions through integration of basic, preclinical, and translational approaches involving molecular, cellular, and physiological mechanisms.